Academic impacts of language delay on oral and written discourse

In response to PAR‐24‐045, we will “leverage existing data and create open and shared data resources to aid in
identifying patterns and predictors of developmental outcomes in late talking children, and exploring potential
underlying (its) mechanisms, risk factors, and sequelae” by using archival resources and TalkBank computational
software to track written language delay as students transition through school age. Specifically, we will track linguistic
microstructure development in written language samples from students from grades 6 to 11, with and without DLD.
Roughly 20‐30% of late talking (LT) children will continue to lag behind typically developing (TD) children throughout
development and be later labeled as Developmentally Language Disordered (DLD). Their deficits become apparent in
writing across all academic genres but little data exist to aid us in developing specific syntactic/grammatical intervention
targets in the written mode. Prior research has addressed limited aspects of language microstructure, such as sample
length or lexical diversity, that provide little guidance on how to develop individualized, focused interventions.
Aim 1 will track writing skills in a carefully stratified, large corpus of persuasive essays (PERSUADE; Crossley, et al.,
2022) from the later elementary through secondary school years, and focus on development of written language
proficiency in native English language‐learning students with DLD and their TD peers. PERSUADE is an immense open‐
access collection (~25,000 samples) of student writing annotated for demographic features such as sex, race, home
language, SES, and disability status. We will further annotate this corpus to identify syntactic, lexical and spelling
features of the samples on an utterance‐by‐utterance basis. We will identify specific, actionable microstructure profiles
that distinguish typical student writing performance from that of students who continue to be identified as language‐
learning disordered. Results will further inform the extremely sparse literature on either typical or disordered written
language trajectories over the school years from grades 6‐11.
Aim 2 will produce a free, open‐access software deliverable, a “writing report card” (AcadEval) available for use
by the wider research, clinical and teaching community for evaluation and intervention planning purposes. AcadEval
will generate individualized profiles of student strengths as well as intervention needs (benchmarked to our statistical
analyses) that can be used to augment current, holistic rubrics and other performance data for benchmarking student
writing progress.
We will also produce a newly annotated corpus for data‐sharing by other researchers and new open‐access
computational resources (software) for research, educational and clinical purposes. We will enhance diverse
perspectives in both research focus and application: We continue ongoing work to distinguish English language
variation (e.g., use of African‐American English and other variants) from disorder using PERSUADE and its unique
demographic features. Finally, our lab recruits highly diverse students for whom our research approach provides
flexibility to engage in research that removes many traditional barriers to participation.

Public health relevance
Children who do not outgrow a history of late-talking (LT) experience lasting adverse academic, social and vocational impacts. Our project uses open-access, existing samples of student writing from age 5 years through Grade 11 and builds a software program for teacher/specialist use that can create individualized reports contrasting a language-impaired student’s grammar, syntax, vocabulary and spelling with grade-level peers. These reports, in turn, can permit more effective intervention to help these students than is currently available, and can minimize public health sequelae of LT.